Long-acting multi prevention implant for 2-year contraception and HIV PrEP

PROJECT SUMMARY/ABSTRACT
Maternal mortality and AIDS are among the leading causes of death in reproductive-age women globally due to
unintended pregnancy and the disproportionate burden of HIV infection. While effective prevention methods
exist, only 21% of women have access to modern contraceptives and adherence to HIV PrEP regimen is poor
in many HIV-endemic regions. Multipurpose prevention technologies (MPT) aim to synchronize contraceptive
delivery with HIV PrEP, offering a patient-centered approach to provide dual coverage to sexually active women
in a single product. A long-acting unified delivery product that can be administered in a discreet manner could
reduce stigma around contraceptives and HIV PrEP, thereby improving uptake and adherence to combination
prevention products. Our goal is to develop a long-acting delivery implant of etonogestrel (ENG) and islatravir
(ISL) drugamer with an unprecedented 2-year release duration for pregnancy and HIV prevention that eliminates
further need of adherence. A new subcutaneous nanofluidic multipurpose implant (NanoMPI) will be brought
together with a new polymeric prodrug technology termed “drugamer”, to achieve this innovative product
candidate that delivers ultra-long acting ENG+ISL drug dosing durations. The NanoMPI leverages a nanofluidic
membrane with nanochannels and a single drugamer reservoir to achieve zero-order release kinetics through
passive diffusion without pumping mechanisms, permitting discreet, user-independent dosing. Key product
attributes will include drug stabilization on the multi-year timeframe, minimized early- and late-stage burst release
and pharmacokinetic (PK) tailing, zero-order drug release kinetics tailored to the individual drug PK/PD
(pharmacodynamic) requirements, user-independent dosing, and retrievability. The project is structured around
3 specific aims: 1) to develop optimized ENG-ISL drugamer formulations that stabilize the drugs and exhibit the
desired zero order release profiles, in concert with the optimization of the NanoMPI device for 2-year sustained
release; 2) to assess pharmacokinetics, tolerability, and safety of the lead ENG-ISL NanoMPI device for 2 years
in pigtail macaques; and 3) to evaluate contraception and HIV PrEP efficacy of ENG-ISL NanoMPI in pigtail
macaques via repeated low-dose vaginal challenge and develop a PK/PD model. We will use a milestone-driven
research approach to advance the ENG-ISL NanoMPI technology towards the ultimate goal of clinical translation,
leveraging the interdisciplinary team’s experience in drugamer technology, drug delivery, pre-clinical and clinical
HIV prevention studies, and hormonal contraceptive and antiretroviral pharmacology. Importantly, the NanoMPI
addresses user preferences for a dual prevention product, discretion and longer dosing duration. Successful
completion will generate a versatile MPT platform that could be adopted for other drug combinations and
preventative strategies.

Public health relevance
PUBLIC HEALTH RELEVANCE Next generation multipurpose prevention technologies that comprise of contraceptive and HIV prevention are urgently needed especially among at-risk women. We propose to develop a long-acting nanofluidic implant offering 2-year constant contraceptive and antiretroviral co-delivery, in a discreet, user-independent and safe manner for long-term use. Successful completion of our proposed work will yield a dual prevention product for advancement towards clinical development to provide women a single, convenient approach to protect their sexual and reproductive health.